Reinforcement as a Prospective Predictor of Real-time Alcohol Abuse Following Bariatric Surgery

ABSTRACT
Recent research has clearly shown that when compared to before surgery, post-bariatric surgery patients are
at increased risk for alcohol use disorders and increased alcohol intake. Understanding the mechanisms that
contribute to these negative clinical outcomes is of considerable scientific and clinical importance. In the
present study, we propose to investigate the extent to which changes in the reinforcement of alcohol lead to
increased alcohol intake in post-bariatric surgery patients. We will employ momentary naturalistic assessment,
objective continuous alcohol measurement, and laboratory methodology to carefully assess reinforcement
using an empirically supported behavior economics-based measure. Additionally, this study is designed as a
prospective, longitudinal investigation that will follow bariatric surgery patients from one year to two years after
surgery.

Public health relevance
NARRATIVE The proposed project will help to elucidate the extent to which changes in alcohol reinforcement promote the development of problematic alcohol intake in post-bariatric surgery patients. The knowledge gained from this study will directly inform both prevention and intervention of alcohol problems with patients who have undergone, or will undergo, bariatric surgery.